The role of 12-lipoxygenase in regulating the effects of EPA on platelet activation and thrombosis

PROJECT SUMMARY
Cardiovascular disease (CVD) is the leading cause of death in the US, accounting for nearly 1 in 4 deaths and
over $400 billion in annual health care cost in the US. Platelet-mediated thrombosis is most common underlying
pathophysiology of cardiovascular diseases and leads to life-threatening clinical cardiovascular events, such as
myocardial infarction or stroke. Under normal physiological conditions, platelet activation is critical for maintaining
normal blood flow following vascular injury, however in pathologic conditions hyperactive platelets can form
occlusive thrombi. Fish oil supplements are one of the most common over-the-counter supplements due to
previous research showing their ability to slow the progression of cardiovascular disease. Fish oil supplements
are highly enriched in the omega-3 polyunsaturated fatty acid (PUFA), eicosapentaenoic acid (EPA).
Supplementation with EPA alone reduces the risk for major cardiovascular events, suggesting the cardiovascular
protection is regulated by EPA, however the exact mechanisms regulating these benefits remain unknown. Our
group has shown that several PUFAs inhibit platelet activation, and these antiplatelet effects are realized through
the production of 12-lipoxygenase (12-LOX) metabolites. Further, we have shown both EPA and its 12-LOX
metabolite, 12-hydroxyeicosapentaenoic acid (HEPE) inhibit platelet activation. However, the exact signaling
mechanisms regulating the antiplatelet effects of EPA and 12-HEPE, as well as the role of 12-LOX in regulating
the effects of EPA on thrombosis are unknown. We will use both pharmacological and genetic techniques to
determine the role of peroxisome proliferator activated receptors (PPARs) and Gαs-coupled GPRCs in regulating
the antiplatelet effects of EPA and 12-HEPE, both of which have been implicated in the signaling of other 12-
LOX metabolites. Finally, we will investigate the effects of supplementation with EPA and icosapent ethyl (IPE),
an FDA approved esterified form of EPA, on the ability to alter plasma 12-HEPE concentrations, platelet
membrane lipid composition, ex vivo platelet activation, in vivo thrombosis, and hemostasis. Additionally, 12-
LOX knockout mice will be utilized to determine if 12-LOX is required for the regulation of platelet activation and
thrombosis by EPA and IPE. Successful completion of this project will, for the first time, elucidate the mechanisms
regulating the ability of EPA to alter platelet function. The findings will be used to inform the use of fish oil
supplements and IPE as a therapeutic intervention for thrombotic diseases to improve cardiovascular outcomes.
Improved use of already available and widely used supplements could reduce the overall burden of CVD.

Public health relevance
PROJECT NARRATIVE Eicosapentaenoic acid (EPA), an omega-3 fatty acid enriched in fish oil supplements, reduces the risk for major cardiovascular events which are highly regulated by platelet hyperreactivity. It has been shown several fatty acids alter platelet activation through their 12-lipoxygenase (12-LOX) metabolites. This proposal seeks to determine the mechanisms by which EPA alters platelet function and thrombus formation through its 12-LOX metabolite, 12-HEPE, which will inform the use of supplements containing EPA in the prevention of thrombotic cardiovascular diseases.